SBIR Phase II: Evaluating the feasibility of the TotalTHM-NOW for drinking water treatment plants to improve water quality, reduce costs, and lower cancer risks

PROJECT SUMMARY/ABSTRACT
There is an increased risk of cancer associated with long-term exposure to drinking water disinfection by-
products (DBPs). Trihalomethanes (THMs) are the most common class of DBPs formed during water
chlorination. Despite the THMs being regulated for 40 years. many drinking water treatment plants (WTPs) still
do not have affordable, on-site tools needed to maintain compliance. Superintendents at these WTPs may
allocate more than two-thirds of their operating budget for treatment processes, with a significant portion being
devoted for THM control strategies. However, without real-time THMs concentration data, WTP operators blindly
adjust the treatment processes which may lead to inefficient practices and higher operating costs. While there
are commercial devices for on-site THMs monitoring, they are not affordable to most WTPs. This is especially
true for very small, small, and many medium sized utilities. Many of these WTP are often rural and located in
economically distressed regions, but they are under the same regulations as their larger Metropolitan
counterparts. The research proposed here will revolutionize water treatment by providing to all WTPs the ability
for affordable, on-site process control of THMs. In Phase I, two instruments were proven to be technically
feasible. The TotalTHM-NOW, where NOW refers simply to getting the results “now”, is based on proven, peer-
reviewed and patented science. The THM Meter is a spin-out device of the Phase I research efforts. Both the
devices are based on the same chemistry, the key difference being that the TotalTHM-NOW is a fully automated,
on-line analyzer for Total THMs whereas the THM Meter is semi-automated. The TotalTHM-NOW will be targeted
at the large number of mid-sized WTPs, large, and very large WTPs. Our lower-cost THM Meter will be the only
device available designed specifically for all very small, small, and medium WTPs. These systems are “game-
changers” with regards to price and performance for an industry that has struggled for almost a decade to meet
affordable price points for on-site THMs monitoring. In Phase II, we will demonstrate the commercial feasibility
of these systems. The specific aims are to reduce the instrument footprint and further optimize the TotalTHM-
NOW to produce beta prototypes; to package and optimize the THM Meter; and to conduct a series of nationwide
beta tests to ready the devices for industry adoption and commercialization. The TotalTHM-NOW and THM Meter
will lead to better process control of THMs concentrations at the WTP, a more complete understanding of THMs
formation, and thus lower THMs concentrations at the plant and in the distribution system. WTPs across the
United States will have the tools they need to: (1) experience fewer THMs violations, (2) reap
economic/environmental benefits through reduced energy and chemical usage, (3) achieve higher community
confidence in their drinking water, and ultimately (4) lower cancer risks through reductions in THMs exposure.

Public health relevance
PROJECT NARRATIVE The trihalomethanes (THMs) are the most common class of regulated, halogenated disinfection by-products and suspected carcinogens. The TotalTHM-NOW and THM Meter instruments developed in this research will provide drinking water superintendents the THMs concentration information necessary to optimize treatment practices and minimize THMs concentrations. Minimization of THMs concentrations over the short-term will aid in compliance with drinking water regulations and over the long-term it will lower cancer risks for whole cities and counties at a time.